Cerebrovascular contributions to cognitive impairment in Lewy body dementias

Project Summary / Abstract
Cognitive decline in Lewy body dementias [Parkinson’s Disease Dementia (PDD) and Dementia with Lewy
Bodies (DLB)] causes significant functional impairment and does not respond well to existing treatments.
Perhaps the largest challenge for developing efficacious treatments in these diseases is the lack of objective
biomarkers for early identification and stratification of PDD/DLB patients based on the location and extent of
neuropathological processes. Cerebrovascular impairment may be an important factor to capture early in the
disease course as there are numerous opportunities for intervention. However, there are several limitations of
the prior research, including: 1) objective measurement of cerebrovascular functions, 2) evaluation of the
frequency and consistency in subject specific cerebrovascular abnormalities, 3) examination of the impact of
cerebrovascular dysfunction on clinical presentation, and 4) examination of the relationship between
cerebrovascular dysfunction and AD plasma biomarkers. The current study addresses these gaps in the
literature and leverages innovative magnetic resonance imaging measures, including: cerebrovascular reactivity
(CVR), the ability of the arterioles and capillaries to dilate in response to a vasodilatory challenge, and arterial
transfer time (ATT) - the travel time of labeled blood to the imaged tissue. This study is both clinically and
methodologically innovative as we use state of the art multimodal imaging to quantify several aspects of
cerebrovascular function and integrate biospecimen analyses to answer key clinical questions. Specifically, PDD
(N = 20), DLB (N = 20), and healthy controls (HC, N = 20) matched on age and sex will be recruited to evaluate
the sensitivity and specificity of novel relative to established MRI cerebrovascular biomarkers and frequency of
abnormal cerebrovascular functions in patient groups (Aim 1). We will then evaluate the relationships between
cerebrovascular abnormalities, AD plasma biomarkers, and cognitive symptoms (Aim 2). At the conclusion of
this successful application, we will identify which cerebrovascular functions are altered in PDD/DLB, the
frequency of cerebrovascular abnormalities in PDD/DLB, and the relationship between cerebrovascular
abnormalities, AD plasma biomarkers, and cognitive outcomes. This information is crucial to developing
interventions for these disorders as potentially cerebrovascular dysfunction may occur early and provide ample
opportunity for intervention. Additionally, in line with the objectives outlined in PAS-19-392, this project will
establish an initial cohort of Lewy body dementia patients that can be expanded through a competitive R01
application to evaluate longitudinal change in cerebrovascular functioning in Lewy body disease across the
cognitive spectrum (e.g. in PD-MCI, prodromal DLB). As part of the current project, the PI will engage in
professional development efforts through several local NIH Centers, enhancing opportunities for networking,
collaboration, and retention in the field.

Public health relevance
NARRATIVE Lewy body dementias present with devastating cognitive impairments, with few available treatment options. Early detection of cerebrovascular dysfunction is crucial as there are treatments available that may already benefit patient groups and reduce long-term disability. The current project will evaluate objective measurements of cerebrovascular functions to evaluate the presence and extent of cerebrovascular dysfunction in Lewy body dementias and how it impacts cognitive outcomes.